Technology Training and Dissemination Core

Core 4 Project Summary
The Technology Training and Dissemination Core leverages the current strengths,
resources and existing programs within our Atlanta-based institutions and supplements
these resources with innovative programs designed to achieve our collective ACME
POCT goals. This Core will play an essential role in ACME POCT functions during initial
global and project-specific needs assessments to help inform the annual project
selection and will also ensure lessons learned and best practices defined through project
lifecycles are disseminated effectively and built into future training curriculum.
Specifically, personnel from the Technology Training and Dissemination Core will
directly interface with all ACME POCT personnel and other relevant stakeholders in
multiple meaningful ways. At the Center level, the Technology Training and
Dissemination Core structure will seek inputs from all stakeholders to define the global
needs assessment and will continuously canvas our environment to collect data related
to lessons learned and best practices. At the program/project level, our Core experts will
conduct an initial Clinical Needs Assessment to drive the selection and “intake” of
microsystem-based POC technologies into the ACME POCT. The Technology Training
and Dissemination Core will also be responsible for developing cross-disciplinary
training activities for all stakeholders involved (clinicians, microsystems engineers, POC
diagnostic developers, patients, public) and will ensure information dissemination is
effective.